Non-Standard Protein Design in Molecular Endocrinology: Insulin and Glucagon

Insulin and glucagon play a central role in the management of diabetes mellitus (DM). This MPI application
combines key clinical objectives of molecular endocrinology with frontiers of structural biology to design analogs
of insulin and glucagon with enhanced pharmacologic properties. Our overarching goal is to reduce the burden
of T1D through an innovative program of “device-driven protein engineering.” Animal studies will be performed
in STZ rats (Subcontract to CWRU) and non-diabetic dogs (Subcontract to Vanderbilt University).
This long-standing R01 program, now in its 30th year, began as a basic investigation of structure-activity
relationships (SARs) in insulin with application to insulinopathies. The general flowering of this field
internationally now affords translational opportunities to enhance T1D technologies while at the same time
enriching basic insights into foundational principles of hormone SARs. Protein design rests upon two premises:
Hypothesis 1: That optimization of the molecular properties of insulin and glucagon (i.e., non-
incremental advances in pharmacologic parameters) can enable transformative delivery devices; and
Hypothesis 2: That such translational research can provide broad scientific guidance for protein
engineering in other diseases and therapeutic spaces.
Our preliminary results suggest that two-chain insulin analogs can be made sufficiently stable and rapid acting
to make feasible prefilled, disposable insulin pumps—and indeed that such pumps may be miniaturized to the
size of a postage stamp (Aim 1). Data are also provided that for the first time suggest that insulin can be made
more potent in vivo on a per nanomole basis and without increased mitogenicity (Aim 2). Such modifications
may find particular utility in basal insulin analogs and reduce the high cost of these formulations (Aim 3). Our
preliminary studies toward ultra-stable glucagon analogs (Aim 4) promise to make practical a one-week
bihormonal pump as part of a closed-loop algorithm-based system. We emphasize these technologies because
they may markedly enhance the long-term health of T1D patients, especially in the adolescent age group.
Aims 1-3 exploit general principles of protein design and protein stability, including both natural amino-acid
substitutions and innovative unnatural amino-acid substitutions amenable to biosynthetic manufacture. Aim 4
generalizes these principles to focus on the exquisite challenge posed by the instability of glucagon.
Protein design will be based both on classical insulin crystal structures and on recent advances in the structural
dissection of the insulin receptor (IR) and its mode of hormone binding. Aims 1-3 thus exploit the ongoing cryo-
EM “resolution revolution” via Subcontract to M.C. Lawrence. An interdisciplinary Approach is proposed by a
unique team with integrated MPI Management Plan. Translational significance is highlighted by the JDRF and
recent American Diabetes Association President L. Philipson (University of Chicago; letters attached). The latter
also indicates potential clinical impact in patients with T2D.

Public health relevance
Project Narrative Standard and non-standard analogs of insulin and glucagon will be designed, synthesized and characterized (in cells, rats and dogs) in an effort to enhance the efficacy and safety of novel delivery devices and closed- loop systems for the treatment of T1D. Non-standard insulin modifications will be sought that, for the first time, enhance in vivo potency without increased mitogenicity, which may decrease per-unit price and illuminate molecular determinants of bio-potency (as distinct from receptor binding). Basic scientific principles underlying protein design will be explored, including structural studies.